Dark GPCR signaling underlying the Microbiome-Gut-Brain Axis for Alzheimer's Disease and Related Dementia

PROJECT SUMMARY
Cumulative evidence indicates the Microbiome-Gut-Brain axis plays a crucial role in Alzheimer’s disease
(AD) and supports the potential of microbiome-targeted therapies as treatments for AD and AD-related dementia
(ADRD). However, the precise mechanism of the Microbiome-Gut-Brain axis and the identity of actionable gut
microbial biomarkers underlying AD/ADRD pathogenesis, disease progression, and modification remind
understudied. Recent advances in chemogenomic technologies have demonstrated that G-protein-coupled
receptors (GPCRs, the largest druggable target family in the human genome, as defined by the NIH-funded
Illuminating the Druggable Genome Program) mediate much of the Microbiome-Gut-Brain axis, especially for
gut microbiota-derived metabolites such as medium-chain fatty acids (MCFAs). Our preliminary experiments
reveal strong significant associations between gut-microbiota MCFA metabolites (e.g., 5-phenylvaleric acid) and
dark GPCR signaling (e.g., GPR84) in AD using multi-omics approaches and an AD patient-induced pluripotent
stem cells (iPSC) model. Furthermore, we identified targeting gut microbial metabolite pathways improve
cognitive behaviors in germ-free mice. We posit that combining AD patient-induced iPSC, cerebral organoids,
and germ-free mouse models, along with multimodal analyses of plasma and hippocampus gut microbial
metabolomics data, will enable improved mechanistic understanding of precise protective mechanisms of the
Microbiome-Gut-Brain axis in AD/ADRD. Our central unifying hypothesis is that identifying likely molecular
drivers (e.g., gut microbial metabolites) and druggable GPCR signaling networks underlying the Microbiome-
Gut-Brain axis will elicit potential prevention and treatment strategies for AD. Aim 1 will test dark GPR84 (a
putative microglial gene) and its signaling activation underlying the Microbiome-Gut-Brain axis of MCFAs via
fecal microbiota transplantation (FMT) in germ-free mice by assessing AD-related cognitive and pathological
phenotypes and mechanisms. We will evaluate differential gut microbial communities, untargeted and targeted
gut metabolomics analyses of plasma and hippocampus in GPR84-/-, 5xFAD, and cross (5xFAD;GPR84-/-)
germ-free mice during pre-FMT and post-FMT. Aim 2 will screen, test and validate dark GPCRs and signaling
network perturbation by gut microbiota-derived MCFA metabolites using AD patient-derived iPSC lines in
conjunction with cerebral organoid models. Specifically, we will evaluate physical binding of the gut microbial
metabolite-GPCR interactome using complementary Calcium flux, cAMP glosensor, and β-arrestin Tango
assays. Aim 3 will conduct supervised analyses of gut microbial metabolite biomarker discovery for, and
prediction modeling of, clinically relevant AD pathological features using patient plasma targeted and untargeted
gut microbial metabolomics. In summary, our multidisciplinary approach comprising germ-free mice, AD patient-
derived iPSC, and cerebral organoid models, along with human plasma gut microbial metabolomics, will identify
potential microbiome-targeted prevention and treatment approaches to be directly tested in people with AD.

Public health relevance
Project Narrative Alzheimer’s disease (AD), a devastating neurodegenerative disease, is estimated that 13.8 million Americans and 152 million people worldwide will be affected by 2050, without effective disease-modifying treatments available. This project will develop and utilize multidisciplinary approaches that assemble germ-free mice, AD patient-induced pluripotent stem cells (iPSC), and cerebral organoid models, along with targeted and untargeted gut microbial metabolomics, for identifying likely molecular drivers (e.g., gut microbial medium-chain fatty acid metabolites) and druggable GPCR (G-protein-coupled receptors) signaling networks underlying the Microbiome- Gut-Brain axis in AD. The successful completion of this project will identify potential microbiome-targeted prevention and treatment approaches to be directly tested in people with AD, an essential goal of NIH’s Alzheimer’s and Related Dementias Research Implementation Milestones.